Enrichment Program

Abstract/Summary – Enrichment Program
The overall goal of the Enrichment Program is to advance basic, clinical and translational
research on nutrition and obesity by fostering scientific interchange among MNORC members
and promoting training and development of students, fellows and junior investigators. To
accomplish this goal, the Enrichment Program will 1) promote active collaboration and
interchange among MNORC investigators with laboratory, clinical or population-based research
on nutrition and obesity; 2) foster interactions among researchers from diverse, relevant
disciplines that can drive discovery and innovation in nutrition and obesity research; 3) advance
training in nutrition and obesity. Our primary venue for cross-disciplinary interaction is the
MNORC symposium and poster session on cutting edge topics in nutrition and obesity research
that have implications for basic, clinical and public health researchers and their trainees across
campus. Additional, weekly research seminars on nutrition and obesity topics that attract
MNORC members feature in-depth discussions of study design, statistical analysis and
interpretation to support rigor and reproducibility in basic and translational research. Bi-monthly
investigator meetings through the Momentum Center/Child Obesity Research Core include not
only presentations of ongoing research but also discussions of measurement standardization,
study design and best practices for recruitment and retention and data collection protocols in
pediatric nutrition and obesity research. Trainees (dietetic interns, medical and graduate
students, fellows and allied health professionals) are provided supervised clinical internships in
the MNORC Cores and Weight Management Program. The expansion of courses in
molecular/biochemical nutrition and nutrition epidemiology and interventions through the
Department of Nutritional Sciences, launched at the School of Public Health in 2015, and via the
School’s new online MPH in Population Health (including a certificate in Precision Nutrition) has
dramatically expanded opportunities to train future health professionals and nutrition
researchers at undergraduate, graduate and post-graduate levels. MNORC investigators
routinely present their research in the Nutritional Sciences bi-weekly seminar. Through the
Enrichment Core, online videos of Core services will allow for easy access by MNORC
members to best practices in human phenoytyping, adipose tissue studies and metabolomics.
Enrichment program activities are integrated and coordinated through the Administrative Core,
ensuring they support rigor and reproducibility across cores’ services and optimize coordination
and interactions among nutrition and obesity researchers and trainees.